Protecting the maternal heart from pregnancy associated heart disease

Project Summary
Postpartum cardiomyopathy (PPCM) is a disease of unknown etiology that arises as
a complication of pregnancy in women with no prior heart disease. It occurs in
1:1800 to 1:3500 births in the United States and is characterized by an acute onset
of heart failure during the last month of pregnancy or within five months postpartum.
PPCM is a major cause of maternal morbidity and mortality with no PPCM-specific
treatment options available. During pregnancy, pregnancy-associated hypertrophy
initiates the activation of cardiomyocyte protective signaling pathways that block
stress-mediated apoptosis. In PPCM patients there is an increase in cardiomyocyte
apoptosis that leads to irreversible dysfunction and heart failure. The cellular
mechanisms driving cardiomyocyte apoptosis are not fully understood. We have
identified a gene PTRH2 (also called Bit-1) that is evolutionarily conserved, mediates
integrin regulated cell survival and apoptosis, and mutations in this gene promote
multisystem disease in humans. We hypothesize that PTRH2 is essential for
cardioprotection from peripartum stresses in the maternal heart. To study this we
developed a cardiomyocyte-specific deletion of PTRH2 (CKO). CKO male and never-
pregnant female mice demonstrate no heart defects and live to old age. However,
100% of CKO pregnant female mice develop PPCM in a dose-dependent manner
(CKO>HET). We will use cell and molecular biology and our CKO mice to determine
how PTRH2 mediates cardioprotection, test whether PTRH2 associated proteins
abrogate the PPCM phenotype in CKO pregnant mice, determine whether PTRH2
expression blocks hypertrophy and examine PPCM patient heart samples for PTRH2
gene mutations. The proposed project has the potential to identify an essential
survival pathway that is activated in pregnancy-associated hypertrophy, test PTRH2
directed therapeutic strategies in a preclinical mouse model of PPCM and determine
whether mutations in PTRH2 promote PPCM.

Public health relevance
Project Narrative The protein PTRH2 plays a protective role in normal cells and loss of this protein results in apoptosis. Heart specific PTRH2 null mice die of postpartum cardiomyopathy (PPCM), which is of unknown etiology and remains a major cause of maternal morbidity in the U.S. The proposed project will identify the molecular function of PTRH2 in PPCM. At the conclusion of this project we will better understand the cardioprotective pathways that attenuate PPCM and determine whether PTRH2 is a viable therapeutic target for PPCM.